Targeting Latency Switch in EBV+ Lymphomas

EBV-associated lymphomas are a heterogenous group of aggressive B-, T-, and NK- cell malignancies. In these
lymphomas, EBV exists in a latent state where infectious virus is not produced but a limited number of viral
proteins are expressed. One mechanism by which EBV+ lymphomas escape the immune response to EBV is
through the latency I program where only the weakly immunogenic Epstein Barr nuclear antigen 1 (EBNA1) and
non-coding RNAs are expressed. Latency I EBV+ lymphomas include Burkitt lymphoma and many cases of
HIV-associated diffuse large B-cell lymphoma. Novel therapies are urgently needed in these subtypes where
the outcome for patients with relapsed disease is dismal (OS<20% in Burkitt lymphoma, for example). In
addition, many of the world’s cases arise in resource limited settings where upfront treatment with high dose
chemotherapy is not feasible. Our approach to this unmet need in EBV+ lymphomas is to use epigenetic
reprogramming to convert latency I tumors to the highly immunogenic latency II or III program, thereby rendering
tumors sensitive to T-cell mediated killing. Using a high-throughput pharmacologic screen, we identified the
hypomethylating agent decitabine as a potent inducer of latency II and latency III antigens in latency I EBV+
lymphomas. Furthermore, we observed that decitabine treatment in latency I tumors sensitizes resistant cells to
killing by allogeneic EBV-specific T-cells, both in-vitro and in-vivo. Based on our preliminary findings, we
hypothesize that epigenetic induction of latency switch in EBV+ lymphoma induces an anti-tumor immune
response capable of eradicating disease through cytotoxic T-cell recognition of latency II/III viral epitopes. In the
current proposal we will develop a rational approach to the use of epigenetic modulation to induce latency
switching and immune mediated cell death in EBV+ lymphomas. We will determine which immune effector cells
are required to eradicate latency switched EBV+ lymphomas including their activation status and function, and
will characterize the predominant viral antigens to which they are responding. We will also explore mechanisms
of potential resistance to decitabine mediated latency-switching and develop therapeutic combination strategies
that maximize the percentage of cells that convert from latency I to latency II/III. Finally, we will establish
therapeutic approaches that enhance the immune destruction of latency switched EBV+ lymphomas.
Collectively, this proposal will accomplish the rational development of an entirely novel approach to the treatment
of latency I EBV+ lymphomas, utilizing epigenetic reprogramming to induce immunogenic viral antigens in
otherwise immunologically silent tumors. This work has implications beyond lymphomas to all EBV+
malignancies with restricted latency.

Public health relevance
Project Narrative Many EBV+ lymphomas are able to evade the anti-EBV immune response through the restricted latency program I where only the weakly immunogenic EBNA1 protein is expressed. Here we will develop a novel approach to the treatment of EBV+ lymphomas by using hypomethylating agents to convert latency I tumors to the highly immunogenic latency III program, thereby sensitizing resistant tumors to an EBV-directed anti-tumor immune response.